Mapping the Dynamics of Caregiver Burden in Alzheimer's Disease

SUMMARY AND ABSTRACT
In this Mentored Research Scientist Career Development Award (K01) Mapping the Dynamics of Caregiver
Burden in Alzheimer's Disease, medical anthropologist and health policy researcher Dr. Alissa Bernstein, PhD,
MPH, based at the University of California, San Francisco, requests research and salary support to provide
protected time and dedicated mentored training in her transition to becoming an independent investigator. Dr.
Bernstein's goal is to build the skills and knowledge required to become an independent investigator who can
use mixed methods to understand and address challenges that occur at the intersection of clinical practice, the
community, and policy in dementia. The research project proposed in this application focuses on the challenge
of caregiver wellbeing as a first step towards her long-term career objective. Through the project, Dr. Bernstein
aims to integrate knowledge about the social and environmental conditions of caregivers of individuals with
Alzheimer's disease into understandings of caregiver burden, resilience, and resource use.
To become an independent researcher, Dr. Bernstein will be supported by an outstanding mentorship team of
clinicians and social scientist researchers at UCSF, a world-class research and training institution with a strong
commitment to multidisciplinary research and clinical practice focused on dementia, aging, and caregiving. Dr.
Bernstein will utilize these resources to develop knowledge and skills in the following areas through
coursework, seminars, mentored tutorials, and practical experience: (1) Geographic Information Systems (GIS)
technology; (2) Advanced mixed-methods research and data analysis; (3) The science of caregiving in
dementia; (4) Professional advancement skills required for independence.
Using these skills, the proposed research assesses the social and emotional experiences and spatial
movement of caregivers of people with Alzheimer's disease (AD) in the home and community. Over 15 million
family members or friends provide care for individuals with AD or other dementias in the U.S. Many caregivers
experience caregiver burden, and are at a high risk for social isolation and loneliness, all of which can have
negative impacts on health and wellbeing. Yet, only a quarter of caregivers access support resources. We do
not fully understand how to intervene in caregivers' experiences in the home and community to reduce burden.
The proposed research will be conducted amongst spousal caregivers of people with AD through the following
research aims: (1) Map and analyze the objective spatial activity of family caregivers living with people with
Alzheimer's disease; (2) Examine and characterize family caregivers' subjective social networks and emotional
experiences; and (3) Create and analyze integrated visual representations of objective spatial data and
subjective social experiences to identify potential interventions. This research will provide guidance in
designing interventions integrating qualitative and spatial analyses to improve caregiver wellbeing.

Public health relevance
PROJECT NARRATIVE Caregivers of individuals with Alzheimer's disease are at risk for loneliness, social isolation, and burden, all of which impact health and wellbeing and pose a growing public health problem. The proposed research will use Geographic Information Systems (GIS) technology, ethnography, and surveys to analyze and map caregivers' experiences in order to identify social and environmental factors that support caregivers or contribute to burden. Results will be used to design interventions for future studies to improve the lives, visibility, and resource use of caregivers of individuals with Alzheimer's disease and to address this pressing health and social need.